ARIEL PROJECT

This is an investigation of the role of viral burden and viral phenotype in facilitating transmission as well as the role of maternal antibodies in protecting against transmission of HIV-1 from infected mothers to infants. Study results should be available in 1997.